GLUCOSE ENHANCEMENT OF MEMORY/ATTENTION IN SCHIZOPHRENIA

The proposed preliminary study specifically aims to 1.) test hypothesis that glucose can reverse memory deficits in older patients with more and less severe cognitive impairment, 2.) address age-related effects on glucose-induced alterations in cognitive functioning by comparison of younger and older groups of patients with schizophrenia, and 3.) further define the dose-response relationship between glucose administration and cognitive performance in schizophrenia by comparision of two oral glucose doses to placebo.